Translational Virology

PROJECT SUMMARY (See instructions): Core K - Current HIV research often requires reliable links between clinical and basic science investigators. These links include characterization and access to clinical specimens, laboratory based assays designed for clinical specimens, interpretation and management of generated data, and training in these areas. The Translational Virology (TV) Core of the UCSD CFAR is designed to be this reliable and cost-effective link. The TV Core accomplishes this goal for a wide range of HIV research-related activities involving: junior and senior investigators, established and burgeoning programs, clinical and basic science investigators, domestic and International efforts, NIH and other funders, etc. Over the past 4 years, the TV Core has provided services to 67 Investigators, contributed to 56 publications, helped 11 investigators obtain new or competing research awards and trained 48 individuals in safe laboratory procedures for working with HIV and PCR methodologies. Specifically, the TV Core provides services through four defined units that work closely with other CFAR Cores, as outlined: (1) Specimen Unit: obtains, processes, tracks, ships and cryostores samples, (primary collaborating Core: Clinical Investigation and Biostatistics) (2) Assay Unit: develops and provides a wide-range of clinically-relevant assays (HIV genotyping, viral loads, antibody and nucleic acid detection, etc.). (primary collaborating Core: Genomics and Sequencing) (3) Quality Control Unit: provides quality control procedures for domestic and International CFAR-affiliated investigators, and analytical support for generated data, (primary collaborating Core: Bioinformatics and Information Technologies) (4) Training Unit: provides training and certification in BL2 and BL3 safety and procedures, specimen processing, PCR, genotyping techniques, and laboratory quality assurance, (primary collaborating Cores: Developmental and International

Public health relevance
RELEVANCE (See instructions): The Translational Virology (TV) Core provides essential Infrastructure and services to support new and ongoing HIV research through the UCSD CFAR. Specifically, the TV Core provides research support in clinical specimen management, relevant assays, analysis and quality assurance of assay data, and lab training. These services support the HIV research needed to better the lives of people living with HIV and for the public health as a whole.